Postgraduate Training Program in Medical Imaging (PTPMI)

PROJECT SUMMARY / ABSTRACT
The Postgraduate Training Program in Medical Imaging (PTPMI) provides recent doctoral graduates with
research training in medical imaging technology as it pertains to normal and pathophysiological functions
applied to nuclear medicine (PET and SPECT), magnetic resonance imaging (MRI), Optical Imaging, Image
Processing and Artificial Intelligence (AI). The importance of the field of Medical Imaging Sciences has been
recognized by the establishment of the National Institute of Biomedical Imaging and Bioengineering (NIBIB).
And within medical imaging science, imaging research and technology and more recently AI have
revolutionized the practice of Radiology. Trainees may enter the field of medical imaging research after study
of a curriculum that focuses directly on radiological science or after earning a doctoral degree in the physical
sciences, mathematics, biophysics, or computer science. MDs with established professional interest in
quantitative imaging research are also encouraged to apply.
The PTPMI provides trainees an innovative training and strong background via customized and diverse
mentoring as well as structured didactic courses and seminars, enabling graduates to critically evaluate the
field and develop their own research ideas. Trainees participate in leading--‐edge research, with the
opportunity to interact with a world--‐class multi-institutional faculty in a setting that combines the resources of
the Harvard Medical School (HMS), and the Harvard--‐affiliated Teaching Hospitals.
The rationale for this program is based on several factors: 1) the growing need for basic scientists with
training in medical imaging sciences applied in modalities such as PET, SPECT, MR, CT and optical; 2) the
availability of outstanding research programs that provide exciting opportunities for trainees in imaging
technologies and AI; 3) the availability of cutting-edge facilities with commercial and prototype imaging
systems; 4) an unusually strong and diverse group of mentors and, in addition, a faculty who provide
additional expertise and extend the range of contacts available to trainees; and 5) long--‐standing, diverse
collaborations, both within the Massachusetts General Hospital (MGH) as well as HMS, other HMS--‐affiliated
hospitals, Harvard University, and the Massachusetts Institute of Technology (MIT).
PTPMI has been characterized over the past funding period by exceptionally strong outcomes in terms of
inclusion and diversity with 32% of T32 trainees URM and 36% women, as well as in terms of career
outcomes with 60% T32 alumni in academic positions and 40% in industrial R&D positions, all in areas
directly related to NIBIB priorities in biomedical imaging and bioengineering technologies.

Public health relevance
PROJECT NARRATIVE The Postgraduate Training Program in Medical Imaging (PTPMI) addresses unmet needs in medical imaging technology as it pertains to normal and pathophysiological functions in a unique multi-institutional research environment at MGH, HMS and MIT. The PTPMI provides a multidisciplinary approach to training with customized, diverse mentoring with exciting research opportunities for the new generation of diverse imaging scientists. Outcomes from the previous period are exceptionally strong both in terms of diversity and inclusion as well as scholarship and career success in biomedical areas directly related to NIBIB priorities.